Mechanisms of Cell Competition in Growth and Development

Project Summary
The central problem this work addresses is how cells communicate their fitness and
recognize aberrant fitness differences that might endanger growing tissues. Much evidence
indicates that the recognition of fitness disparities elicits interactions that prevent the
weaker cells from contributing to the animal, promoting optimal tissue and organismal fitness.
Cell competition is a mechanism that facilitates this homeostatic process, and is initiated
upon recognition of cells perceived as less fit by their more robust neighbors. Examples of
competitive behavior between cells of different fitness are numerous, but the best studied those
induced by reduced ribosomal proteins (Rp), or reduced or enhanced expression of the
transcription factor Myc. The developing Drosophila wing is the critical paradigm for study of
cell competition - as a model system it is unsurpassed for mosaic studies of cell-cell
interactions in living animals, and offers unparalleled genetic and molecular toolkits. We
recently discovered that communication between the “winner” and “loser” cells is mediated by
a novel signaling pathway consisting of components co-opted from the highly conserved
innate immune response pathways. Our long-term goal is to explore both proximate (how does
this work) and ultimate (what is it for) questions about cell competition. In this proposal, we
focus on three major quests: 1), to further explore the mechanism by which signal activation is
controlled and restricted to only nearby “loser” cells; 2) to delineate the endogenous role
of cell competition during normal animal physiology; and 3) to investigate the existence of a
general mechanism of cell fitness sensing.

Public health relevance
Project Narrative Optimal tissue fitness and animal health requires cells to cooperate with each other for normal tissue function. The long-term goal of our studies is to define the molecular mechanisms of cell competition, a process of cell fitness comparison, in the context of tissue growth and overall animal physiology, which should provide new approaches for preventing developmental defects and promoting optimal health.